Theranostic Nanovesicles for Ocular Angiogenesis Therapy

The current standard of care for wet age-related macular degeneration (AMD) with intravitreal injections of
vascular endothelial growth factor (VEGF) inhibitors has transformed the treatment paradigm. However, many
AMD patients with choroidal neovascularization (CNV) either fail to respond to anti-VEGF therapy or suffer
from complications associated with repeated intravitreal injections. Therefore, there is great need for
developing alternative treatment modalities, including novel therapeutic agents and delivery methods, to
combat CNV for patients with AMD.
The selective expression of certain integrins on choroidal and retinal neovasculature makes integrin an
ideal target, while delivery of integrin antagonists can be engineered using stem cell-derived nanovesicle
system that is biocompatible and amenable for crossing the ocular barriers. We hypothesize that modification
of the stem cell-derived, superparamagnetic iron oxide particle (SPIO)-labeled exosomes to deliver an integrin
antagonist will provide a potent theranostic agent to effectively inhibit or regress CNV with the ability to directly
visualize and quantitatively assess drug distribution in vivo. In Specific Aim 1, we will develop and fully
characterize the nanovesicle formulations and test their cytotoxicity, antiangiogenic property, as well as
magnetic particle imaging (MPI) sensitivity. In Specific Aim 2, we will test the hypothesis that the engineered
nanovesicle system improves the therapeutic efficacy of CNV in vivo and enables MPI imaging for longitudinal
quantification of drug distribution. In this aim, we will determine the effect of SPIO-labeled, drug-conjugated
nanovesicles on Iaser-induced CNV and analyze the kinetics of drug distribution by noninvasive MPI imaging.
The proposed study brings a unique combination of expertise in ophthalmology, drug delivery, MPI
imaging, and animal model of retinal diseases, to address the critical challenges for efficient drug delivery into
the posterior segment of the eye. Successful completion of the proposed activities will have vast ramifications
for advancing the development of stem cell-derived nanovesicles as novel theranostic agent for treating ocular
vascular diseases and other angiogenesis-related disorders.

Public health relevance
Ocular neovascularization occurs in a broad spectrum of ocular diseases that lead to severe vision loss, but current therapies replying on repeated intraocular injections fail to achieve vison improvement in many patients. The proposed study is to develop a stem cell-based nanoparticle delivery theranostic system that can be targeted to the neovascular lesions and be directly visualized to quantitatively assess drug distribution in the eye. These studies will advance the development of imaging-visible drug delivery system that will address unmet needs in the treatment of ocular vascular diseases.